High resolution genomic and epigenomic mapping of the human salivary gland

PROJECT SUMMARY
A mechanistic and molecular examination of the differentiation programs and normal tissue
homeostasis of the salivary glands (SG) is an important area of research since altered SG function is
associated with multiple human disease conditions including Sjogren syndrome, cancer, and complications due
to cancer chemo/radiation therapy. This necessitates an in-depth investigation of the complex ecosystem of
SG that consists of a variety of epithelial and non-epithelial cell populations that cooperatively interact to
facilitate SG function. The underlying molecular circuitry of the transcriptional and epigenomic gene-regulatory
mechanisms that control SG biology, particularly as it pertains to individual cell types in the in vivo context of
the human SG, however, is not very well-understood and thus presents a significant knowledge gap. Lack of
this knowledge prevents a better understanding of principles of cell fate and lineage choices, cell-to-cell
communication and transcriptional regulatory processes that are needed for guiding effective therapeutic
interventions of human diseases. Our central hypothesis is that the establishment of the SG transcriptome,
epigenome and gene regulatory networks is a dynamic process that results from reciprocal interactions
between intracellular signaling pathways and the underlying hardwired genomic information of each cell-type.
To test this hypothesis, three specific aims are proposed. Aim 1 is to generate single-cell RNA-sequencing
(scRNA-seq), and scATAC-seq data from the same cells of the adult male and female SMG. The goals of Aim
2 are to use computational tools to define the cell fate trajectories and cell-to-cell communication systems that
operate in the SG and identify crucial transcriptional regulators that define cell fate. Finally in Aim 3, the 3D
chromatin state and the enhancer-promoter connectome map of the human SG will be established by HiChIP
experiments. Such data will enable the establishment of the link between non-coding genetic variants and
disease-associated genes that are relevant for disease such as Sjogren’s syndrome that primarily afflict the
SG. This work is highly innovative and significant because our proposed use of cutting-edge technologies and
sophisticated tools to examine fundamental transcriptional and epigenomic mechanisms of gene regulation
and signaling pathways at a single cell resolution. Long term, such knowledge will substantially advance the
fundamental understanding of SG biology and is anticipated to have a long-term impact on the treatment of
complex genetic diseases of the SG.

Public health relevance
NARRATIVE Cell fate determination, differentiation, tissue homeostasis and functional specialization of the human salivary gland is a tightly regulated and dynamic process that requires the coordinated action of various cell populations that communicate with each other. This application focuses on examining at high resolution, cell-type specific transcriptional and gene regulatory mechanisms that play important roles in SG biology. Such studies will lead to an improved understanding of various conditions afflicting the human salivary gland such as ageing, autoimmune and inflammatory diseases, and cancer.